Elucidating the Role of the Thousand and One Kinases in Retinal Ganglion Cell Death

Abstract
Glaucoma causes irreversible, progressive vision loss via axon injury and subsequent cell death of retinal
ganglion cells (RGCs). Current treatments aim to lower intraocular pressure, although this is insufficient in some
patients and associated with complications in others. As such, it is proposed herein to develop complementary
strategies to mitigate axon injury signaling. From previous high-throughput functional genomic screens in RGCs,
dual leucine zipper kinase (DLK) and its paralog, leucine zipper kinase (LZK), emerged as central players in the
cell-autonomous pathway causing cell death following axon injury via upstream regulation of JUN N-terminal
kinase 1-3 (JNK1-3). Despite DLK/LZK’s role as master regulators of RGC cell death following injury, their
regulation is poorly understood. Further investigation of DLK and its interactions has the potential to reveal the
upstream regulatory mechanisms involved in RGC death and thus, additional therapeutic targets.
In an additional high throughput screen of the entire kinome in mouse RGCs, the thousand and one (TAO)
kinases, specifically TAOK1 and TAOK2, surfaced as key mediators of cell death. Combined knockouts of
Taok1 and Taok2 promoted robust and sustained RGC survival in the mouse optic nerve crush (ONC) model.
The central hypothesis of this proposal is that TAOK1/2 work as regulators of the DLK/LZK/JNK signaling axis
and mediate neuronal cell death in response to axon injury. This hypothesis will be studied in a rodent model
and in human stem cell-derived RGCs using pharmacological and viral-based tools combined with CRISPR/Cas9
gene editing to produce loss- and gain-of-functions.
Aim 1 will elucidate the relationship between the TAO kinases and DLK/LZK/JNK in axon injury signaling, by
genetically probing the upstream/downstream relationship of these key kinases in vitro and in vivo in mice. Aim
2 will explore the role of TAO kinases in cell death signaling using an in vitro model of human RGCs.
If successful, the work proposed herein will shed light on the role of the TAO kinases in the pathway
responsible for RGC death in a mouse model and in human stem cell-derived RGCs. The neuroprotective
potential of TAO kinase inhibition has yet to be fully understood and could be leveraged to mitigate RGC
death and vision loss in glaucoma. Furthermore, with the completion of Aim 1, the principal investigator will
acquire new skills in adenovirus and AAV production, histological and functional measures of RGC
neuroprotection, and viral/CRISPR-based approaches to manipulating gene function. With the completion of Aim
2, the principal investigator will acquire new skills in human stem cell culture and RNA sequencing. The principal
investigator will greatly benefit from working under the direct supervision of the sponsor on this proposal, Dr.
Derek Welsbie, an expert in glaucoma and DLK/LZK signaling, and the co-sponsor, Dr. Karl Wahlin, an expert
in the directed differentiation of stem cells into retinal tissue. Advisement from a committee of experts in the field,
continued coursework and access to core facilities at UC San Diego will also be a boon to his training and efforts.

Public health relevance
Project Narrative We previously identified dual leucine zipper kinase (DLK) and leucine zipper kinase (LZK) as the master regulators of the signaling pathway that mediates cell death following axon injury as observed in optic neuropathies like glaucoma. Using a clustered regularly interspaced short palindromic repeat (CRISPR)-based screen in primary retinal ganglion cells, we identified the thousand and one kinases 1 and 2 (TAOK1/2) to be previously unknown participants in the DLK/LZK signaling and thus, promising neuroprotective targets. In this proposal, we develop and use novel adenovirus and adeno-associated virus/CRISPR vectors and pharmacological means to test the hypothesis that TAOK1/2 work as regulators of the DLK/LZK/JNK signaling axis and mediate neuronal cell death in rodent and human in vitro models of optic neuropathy.